Cancer Research Career Enhancement

CANCER RESEARCH CAREER ENHANCEMENT (CRCE) CORE: SUMMARY
The CRCE Core leads, facilitates, and coordinates cancer research education and training. It provides
educational opportunities throughout the training pipeline from high school to junior faculty. This is achieved
through a rich research environment, numerous training grants, and the conduct of scientific seminars, journal
clubs, workshops, networking, and mentoring activities; all part of HICCC membership activities. A new initiative
will be the CRCE Core’s emphasis on unique training opportunities in precision medicine and health disparities
for basic, clinical, and population scientists. The CRCE Core works with the Community Outreach and Education
(COE) Core to ensure that training is focused on enhancing our deep commitment to the HICCC’s catchment
area (CA), which is racially, ethnically, and socioeconomically diverse. The CRCE Core coordinates and
collaborates with other institutional efforts including Columbia’s NIH Clinical Translation Science Award (CTSA)
and the Columbia University Precision Medicine initiative in order to maximize impact while reducing overlap.
Wendy K. Chung, MD, PhD leads the CRCE Core, and she is also a member of the Cancer Genomics and
Epigenomics (CGE) Program. Chung, Kennedy Family Professor of Pediatrics and Medicine, is a clinical and
molecular geneticist who directs the clinical cancer genetics program at Columbia University and has led
fellowship programs in molecular and cytogenetics. A CRCE committee and program manager support Chung.
As Associate Director of Education and Training in the HICCC, Chung plays critical roles in the strategic plan of
the HICCC. The CRCE Core has interrelated Specific Aims that span all training stages and promote patient
focused and transdisciplinary, collaborative research.
Aim 1: High school and undergraduate students: Provide engaging exposure to cancer research with the
HICCC mentors for a diverse community of high school and undergraduate students in New York City.
Aim 2: Graduate and health professional students: Provide integrated, interdisciplinary cancer research
education, training, and mentoring opportunities for graduate (Master and PhD in the medical, nursing, dental
and public health schools) and medical, nursing and dental students.
Aim 3: Postgraduate fellows and faculty: Enhance career development for postgraduate trainees and faculty
at all levels by supporting continuing education and training, developing critical thinking, grant writing, and
presentation skills, and providing mentorship support to mentors and mentees.
The CRCE core trains a transdisciplinary workforce, recruits and retains underrepresented minority trainees and
faculty, and uses a data-driven approach to develop and refine enduring educational resources across the
pipeline of trainees. The CRCE Core facilitates the training of the next generation of cancer researchers for
successful careers in diverse settings. Testimony to the equivocal support from the HICCC will be investment of
at least $2.4M administrative support ($.5M) from non-CCSG sources.